Central oxytocin mechanisms of pain recovery following nerve injury

Oxytocin produces antinociception in rodents in a variety of pain states, however the
mechanisms by which this occurs and the importance of peripheral versus central effects are
unclear. Prior studies have typically used systemic administration of oxytocin, with dosing-to-
effect strategies in the absence of pharmacokinetic data or consideration of brain penetrance.
These studies can only be extrapolated to the clinic after relevant dosing parameters have been
determined experimentally to achieve peripheral and central oxytocin exposure across rodents
and humans, and using such parameters to compare antinociceptive efficacy against different
outcome measures, with subsequent exploration of potential mechanisms. This Project
translates and is informed by Projects 1 and 3 to define the pharmacokinetics of oxytocin in
awake and anesthetized rats in brain and blood and determine the relevance of peripheral and
central action of oxytocin on complex behaviors following nerve injury. Three specific aims are
proposed. The first aim will define the pharmacokinetics of oxytocin in plasma and brain using
i.v. bolus, and these data will be used to design targeted concentration infusion paradigms in
the PK/PD core. The rate of brain entry and loss will also be assessed. The second aim will take
advantage of a novel transgenic rat developed by our group that expresses Cre recombinase
selectively in oxytocinergic neurons. We will determine the role of endogenous oxytocin circuits
in modulation of complex behaviors after peripheral nerve injury using Cre dependent neuronal
ablative strategies, expressing mutated caspase 3 in targeted neurons. We have developed
novel behavioral methods that assess impairment of attention, fear avoidance, and affective and
sensory modalities of pain after nerve injury and use these innovative behavioral methods for
this aim. The third aim combines the knowledge gained from Aims 1 and 2 to assess the
efficacy of oxytocin in mitigating the behavioral changes induced by peripheral nerve injury,
tests the potential for oxytocin to produce long-lasting, disease-modifying effects in behavior
and afferent physiology, and the role of endogenous circuits in these effects. This project
interacts with Project 1 to assess the contribution of altered primary sensory afferent signaling in
complex behaviors and the relevance of oxytocin and with Project 3 to target relevant peripheral
levels of oxytocin in humans for peripheral and central action.

Public health relevance
Oxytocin has been shown to be analgesic under some circumstances in preclinical animal models, however most of these studies use dose-to-effect strategies and simple reflexive behavioral measures. In this project, we model oxytocin pharmacokinetics in rats and use targeted concentration infusion paradigms to determine the effects of oxytocin in complex behaviors modified by peripheral nerve injury. We also modulate endogenous oxytocin circuits using a transgenic rat that expresses Cre recombinase selectively in oxytocinergic neurons. Together with similar studies assessing the effects of oxytocin on primary sensory afferents in rats and humans, and on human oxytocin pharmacokinetics and primary afferent physiology in the program project grant, these studies will provide evidence for or against an important role for oxytocin in promoting recovery from injury and mitigation of chronic pain.